RFA-GH-23-003, THAI-GER: THAIland Genomic surveillance of Emerging infectious diseases facilitating Rapid response

Abstract/Project summary:
Emerging infectious diseases (EIDs) and re-emerging infectious diseases (REIDs) can
spread quickly among immunologically naïve populations, triggering epidemics or pandemics.
Antimicrobial resistance (AMR) is another public health issue responsible for numerous fatalities
and economic losses. The government-associated infectious disease laboratories in Thailand are
structured in a centralized manner whereby samples are first collected by community hospitals
and then transferred to regional and central laboratories for testing and analysis. While this
approach is effective in managing seasonal diseases and small epidemics, it can cause delays in
detecting and controlling diseases during larger outbreaks. Apart from specific and sensitive
laboratory-based tools to manage EIDs, communities need field-deployable, simple technologies
which can be used for EID surveillance. Surveillance systems play a critical role in monitoring and
predicting outbreaks of infectious diseases. To enhance surveillance capabilities, it is necessary
to develop simple but high sensitivity and specificity laboratory tools that can identify EIDs, REIDs
and antimicrobial resistance capabilities in both central and local laboratories, including
bioinformatic pipelines, microbial genomic databases, and laboratory management systems. The
development of genetic analysis platforms will help facilitate the analysis of pathogen genomes,
particularly when dealing with a large volume of data. To enhance the ability of government
agencies and local communities to detect, monitor, and surveillance EIDs (respiratory viruses,
arboviruses, bacterial STIs, and nosocomial bacterial pathogens) and AMR, we propose the
development of coordinated, multi-level tools and systems. These tools and systems will facilitate
early detection and rapid response to EIDs

Public health relevance
Project narrative: We propose to develop molecular diagnostic tools (TaqMan Array Card platform and POCT CRISPR) for centralized and decentralized laboratories and establish a genetic analysis platform (Short-read and Long-read sequencing), bioinformatic pipelines, and microbial genomic database to facilitate genomic surveillance of respiratory viruses, arboviruses, bacterial STIs, and nosocomial bacterial pathogens, including antimicrobial resistance. These multi-level tools and systems will facilitate early detection and rapid response to EIDs and AMR across different levels of government and local communities.